Deciding about Dialysis: Improving Decision-Making Among Older Adults with ESRD

Individuals 70 and older are the fastest growing group of patients with end-stage renal disease (ESRD).
Research shows that decision-making regarding initiation of dialysis is impaired by poor communication and
lack of understanding about the options for management of ESRD. Some small studies suggest that, among
older adults, dialysis is likely associated with longer life expectancy compared to conservative management
without dialysis. Yet little is known about what older adults can expect after initiating dialysis in terms of patient-
centered outcomes such as functional status and cognitive function. Furthermore, there has been little research
into patient, family, and clinician perspectives on this decision-making process.
This proposal has the following three complementary aims that address these challenges related to
dialysis decision-making: 1) Define the trajectories of functional status and cognitive function for adults 70 and
older with ESRD before and after initiation of dialysis, compared to the trajectories of adults not on dialysis. 2)
Explore perspectives about the decision to initiate dialysis (versus conservative management) among adults 70
and older, their families, and clinicians. 3) Develop a decision aid for older patients with impending ESRD.
The first project is a quantitative analysis using nationally-representative longitudinal survey data from
the Health and Retirement Study. The second project features qualitative interviews with patients, families,
and clinicians about the dialysis decision-making process. The third project will use the knowledge gained from
Aims 1 and 2 to inform the design of a decision aid for adults 70 and older who are expected to need dialysis.
The overall objective of this K23 Career Development Award (CDA) is to support the early career of Dr.
Melissa Wachterman, a palliative care physician and health services researcher at Harvard Medical School.
Dr. Wachterman is a promising junior investigator specializing in research related to geriatric palliative care.
Her career goal is to become an independently-funded clinician-investigator conducting research that improves
quality of care and patient-centered treatment decision-making for seriously-ill older adults and their families.
This K23 award will help Dr. Wachterman accomplish the following goals: 1) to obtain advanced
training in biostatistics, including analytic skills using longitudinal nationally-representative survey data; 2) to
acquire training in qualitative research methods; 3) to develop skills in decision aid development; 4) to develop
as an investigator to ensure a successful transition from this CDA to independent R01-level funding.
To achieve these goals, Dr. Wachterman has a mentoring team committed to her success as a clinician
investigator. Her primary mentor is Dr. Nancy Keating, Associate Professor of Medicine and Health Policy at
Harvard Medical School and an internationally-recognized health services researcher with expertise in
palliative care. Her co-mentor is Dr. Edward Marcantonio, a geriatrician and internationally-renowned aging
researcher. Dr. Wachterman will benefit greatly from working in Harvard’s vibrant research community.

Public health relevance
Adults 70 and older are the fastest growing group of patients with end-stage renal disease, yet little is known about what they can expect life to be like on dialysis. Furthermore, few resources exist to help patients, their families, and their clinicians decide whether starting dialysis, as opposed to managing their kidney failure with medications focused on decreasing symptoms, is the right choice for them. The proposed study aims to better understand what life is like for older adults on dialysis and how they and their families make dialysis decisions, with the goal of designing a resource to improve patient-centered decision-making about starting dialysis.